Using Connectomics and Machine Learning to Predict Survival in Diffuse Glioma

ABSTRACT
Diffuse gliomas are the most common malignant primary brain tumors. Clinical outcomes, including overall
survival, vary significantly across individual patients and are not adequately explained by known prognostic
factors such as age, histologic and molecular pathology, and imparted treatments. A deeper understanding of
prognostic influences in diffuse glioma can facilitate therapeutic decision making and patient counselling and
lend further insight into the biologic underpinnings of the disease. Magnetic resonance imaging (MRI) scans of
the brain are part of standard pre-operative evaluation in these patients. As brain structure and function are
modulated by biologic and environment factors, MRI-derived metrics often provide sensitive prognostic
biomarkers. We have preliminarily shown that connectomics, a method of measuring brain connectivity from
MRI, can accurately predict survival in patients with diffuse glioma. We will retrospectively obtain at least
1,150 datasets and attempt to validate our preliminary models (Aim 1). We will also examine connectome
phenotypes associated with tumor genotypes to help refine and improve our models (Aim 2). Accurate pre-
operative prediction of outcome may ultimately allow for better tailored interventions for the individual patient
and assist clinicians in optimizing both tumor control and neurologic function in treatment decision making.

Public health relevance
Narrative Accurate pre-operative prediction of outcome following diffuse glioma may ultimately allow for better tailored interventions for the individual patient. The proposed study aims to determine a model for predicting survival and neurocognitive functioning from simple brain scans that are routinely acquired as part of standard of care. This research is highly relevant to diffuse glioma, which is associated with widely variable survival time and time to disease progression.